A Compute Cluster for Brain Imaging and Analysis

? DESCRIPTION: Neuroimaging research using high-resolution functional and structural MRI (including diffusion tensor imaging, or DTI) involves the acquisition and analysis of very large data sets that then must be transformed through a series of computation-intensive processing tasks into meaningful information. This project, entitled A Compute Cluster for Brain Imaging and Analysis, is submitted by NIH-supported investigators at Duke University who primarily conduct neuroimaging research at the Duke - UNC Brain Imaging and Analysis Center at Duke University Medical School. The collaborating scientists have found that the sheer volume of data resulting from improved acquisition and analysis methods has made it increasingly difficult to fully analyze data from all the labs in a timely manner. With our existing computational infrastructure, some processes such as the ultrahigh resolution (submillimeter) diffusion MRI through massive parallel imaging (both in-plane and multi-band through-plane) would take over 20 hrs for a typical ten-run whole-brain functional exam. Also, specific large matrix inversions fo our ultrahigh resolution susceptibility mapping would require memory of up to 700 GB per node. Thus, we are requesting funds to purchase a high- performance compute cluster to meet these and other processing requirements. Our proposal builds upon our past experience administering a 60-node, though quite dated, Linux cluster (Dell PowerEdge 1950), with high-speed fiber channel adaptors and connections to our multiple data servers. We anticipate that this much improved computational resource will greatly enhance our ability to meet the much increased MRI acquisition capability and analysis demand in the many NIH-sponsored research projects, and gain maximum efficiency at lower overall cost. In addition to meeting the computational needs of our neuroimaging scientists, this proposal also benefits from the close collaboration that already exists among us in Duke's big data initiative to have a wider impact.

Public health relevance
PUBLIC HEALTH RELEVANCE: We propose in this S10 application to purchase a 32-blade, 768-core, Hitachi CB500 compute cluster (Intel Haswell microarchitecture) to meet the ever increasing computational demands from our NIH funded neuroimaging investigators, as the results of much improved MR image acquisition and analysis methodologies in the past five years. Because most of our projects share common pre- and post-processing steps such as parallel image reconstructions for ultrahigh resolution brain images and multivariate pattern analysis across large number of subjects, this shared instrumentation will greatly improve the productivity and efficiency of our research projects. We anticipate that this cluster will help us gain maximum computational power at the lowest cost taking into consideration the large amount of projects it will support.